Defining the role of TCAB1 and its phase separation in telomerase assembly.

PROJECT SUMMARY/ABSTRACT
Telomeres, the ends of human chromosomes, shorten every time a cell divides. When telomeres become too
short, human cells stop dividing or undergo programmed cell death. Telomerase adds telomeric DNA onto
chromosome ends to counteract telomere shortening. In the human body telomerase is expressed in stem cells,
allowing them to continuously proliferate throughout our lives. Defects in telomerase function lead to premature
aging diseases such as Dyskeratosis Congenita, which are caused by the depletion of stem cell populations. In
addition, telomerase is expressed in ~90% of tumors and allows cancer cells to proliferate indefinitely. It is
therefore critical to develop targeted approaches to promote or interfere with telomerase activity to treat
premature aging diseases and cancer, respectively. Telomerase is a complex ribonucleoprotein that contains
the telomerase reverse transcriptase protein (TERT), the telomerase RNA (TR), and various co-factors including
the telomerase cajal body protein 1 (TCAB1). TCAB1 is required for telomerase function in human cells but the
mechanism underlying its contribution to telomere maintenance is controversial. Initially it was suggested that
telomerase is properly assembled and fully active in the absence of TCAB1, leading to the model that TCAB1 is
required for telomerase trafficking to telomeres. More recent observations suggest that TCAB1 is required for
telomerase catalytic activity by promoting TR folding without affecting overall RNP assembly. Importantly, all
previous studies clearly demonstrate that TR is enriched in nucleoli in cells lacking TCAB1. Our prior work has
shown that TERT is specifically excluded from nucleoli. We therefore believe that in the absence of TCAB1,
telomerase fails to assemble because TR is trapped in nucleoli and TERT is excluded from nucleoli. Both nucleoli
and Cajal bodies are phase separated nuclear organelles. Phase separation is an emerging molecular
phenomenon by which proteins and nucleic acids from liquid like droplets. In preliminary experiments we have
shown that TCAB1 contains disordered regions that can undergo liquid-liquid phase separation. Our central
hypothesis is that the specific phase separation properties of TCAB1 facilitate telomerase assembly by driving
the exclusion of the telomerase RNA from nucleoli and promoting its interaction with Cajal bodies. To test this
hypothesis, we will address the following specific aims, (1) Determine the role of TCAB1 in telomerase assembly,
and (2) Define the phase separation properties of TCAB1 and dissect their contribution to telomerase assembly.

Public health relevance
PROJECT NARRATIVE Telomere maintenance by telomerase is a critical pathway for tissue homeostasis in the human body and as a consequence, deficiencies in telomerase lead to premature aging diseases and inappropriate activation of telomerase is a hallmark of 90% of human cancers. Telomerase is a multi-component ribonucleoprotein and its assembly is deficient in premature aging disorders and could be targeted to inhibit telomerase activity in cancer cells. The goal of this study is to determine the molecular mechanism underlying the role of TCAB1, an RNA- binding protein essential for telomere maintenance, in telomerase assembly to develop new approaches to target telomerase function for therapeutic purposes.